Developmental Core

SUMMARY DEVELOPMENTAL CORE
A major challenge to including environmental measures to existing studies is capturing the dynamic
nature of the environment, particularly how to capture it retrospectively, yet objectively. This is particularly
important for HHEAR since it may include many case control genetic studies that would be cross-sectional
if blood or urine were used for exposure assessment. The absence of objective retrospective biomarkers
that provide information on both the magnitude and timing of fetal and early childhood exposure to
external environmental exposures and internal biological processes is a major barrier in environmental
epidemiology. A primary mission of the Developmental Core is to develop, validate and standardize
precise, unbiased, approaches of measuring key components of the `exposome'. Our methods are now
capable of measuring 100,000 features in a single scan. However, keeping in mind the need for
reconstructing past exposure, we will further extend this work to retrospective biomarkers of at specific life
stages including prenatal life, effectively providing data equivalent to a prospective longitudinal design. A
major focus will be retrospective exposure reconstruction biomarkers that objectively measure prenatal
and infant environment, which are known to be important for both childhood and adult disease. Our
Developmental Core has an established track record of innovation over the past three years in the
CHEAR Program. We developed tooth matrix-based biomarkers that leverage dentine growth rings to
reconstruct the timing and dose of toxic/nutrient elements and untargeted organic chemical exposures in
fetal life and infancy. We are also developing biomarkers that improve on the standard methods to assess
neonatal dry blood spots, hair and the placenta, all of which can potentially reconstruct past exposure at
different stages of life. It is now recognized that tissue architecture can provide exposure and biological
information on toxicity via chemical spatial distribution. Our Core will apply 2D tissue bio-imaging that
quantifies the spatial distribution of both metals and biomolecules within tissue sections, using high-
resolution laser-based mass spectrometry combined with multiplexed metal-tagged immunolabelling. We
are applying this to cancer studies by mapping solid tumors to include spatial information on
environmental exposures in cancer. This is one prominent example of the Core aims to contribute to
Precision Environmental Medicine. The Developmental Core will integrate with the Untargeted Resource,
so that our work can be incorporated as services offered to HHEAR Clients. This will be accomplished
through shared personnel, resources and the monthly Executive Steering Committee meetings. Our goal
is to bring new biomarkers into the HHEAR network as fully developed, high-throughput platforms. Dr.
Manish Arora is the Core Leader, and Director of the Resource, roles he also played in the CHEAR Hub.